Mechanisms associated with neuroprotection from Mn-induced neurotoxicity.

Project Summary
Chronic exposure to high levels of manganese (Mn) causes manganism, a neurological disorder
which shares multiple pathological features with Parkinson's disease (PD). Mn-induced
neurotoxicity includes decreased expression of tyrosine hydroxylase (TH), a rate-limiting enzyme
in dopamine synthesis, and dopaminergic neuronal injury. But the mechanisms of the Mn-induced
neurotoxicity are not completely understood. Estrogenic compounds, such as tamoxifen, a
selective estrogen receptor modulator (SERM), have been shown to be protective in Mn toxicity
and PD, but their mode of action remains to be established. While the transcription factor RE1-
silencing transcription factor (REST) was initially described as a repressor of neuronal genes in
non-neuronal cells during development, it has recently been shown to play a critical role in
protection of adult neurons, and it activates genes that are involved in neuroprotection. Our
preliminary data reveal that Mn decreased REST, whereas TX increased its expression in TH-
expressing neuronal cells. REST protected dopaminergic neurons against Mn neurotoxicity by
attenuating Mn-induced oxidative stress, inflammation and apoptosis. These findings indicate that
REST may mediate TX-induced neuroprotection against Mn toxicity in dopaminergic neurons.
Therefore, investigating the mechanisms of REST in Mn-induced neurotoxicity and TX-induced
protection against Mn toxicity is critical to advance our understanding of Mn neurotoxicity and in
developing therapeutic strategies to treat neurodegenerative diseases associated with
dysfunction of dopaminergic neurons. We hypothesize that REST protects against Mn
neurotoxicity by enhancing expression of TH, as well as the antioxidant/antiapoptotic genes
catalase (CAT) and B-cell lymphoma 2 (Bcl-2), and mediates TX-induced protection against Mn
toxicity via genomic ERα and nongenomic ERα/GPR30 pathways. Our hypothesis will be tested
in the following specific aims: 1) Test if REST in DAergic neurons is protective against Mn
neurotoxicity in mice, 2) Investigate mechanisms of Mn-induced REST reduction and the
protective effects of REST against Mn neurotoxicity via upregulation of TH, CAT and Bcl-2, and
3) Test if DAergic REST is a critical mediator of TX-induced neuroprotection against Mn toxicity.
The outcome of the study will provide critical information on the role of REST in DAergic neuronal
function, Mn toxicity and TX-induced neuroprotection against Mn toxicity. The results also greatly
contribute to the development of `neuroSERMs' to treat NDs associated with DAergic injury, such
as manganism and potentially PD.

Public health relevance
Project Narrative Chronic exposure to elevated levels of manganese (Mn) causes dopaminergic toxicity including a reduction in tyrosine hydroxylase levels and dopaminergic neuronal function, with ensuing injury to the nigrostriatal pathway, leading to cause Parkinson's disease (PD)-like symptoms, referred to as manganism. Tamoxifen, a selective estrogen receptor modulator (SERM), exerted protection against Mn-induced dopaminergic neurotoxicity. The mechanism by which TX attenuates Mn toxicity is not well understood, but our preliminary findings show that a transcription factor RE1-silencing transcription factor (REST) is critically involved in TX-induced neuroprotection against Mn toxicity. Delineating the molecular mechanism by which REST affords neuroprotection will not only impart novel insight into mechanisms of Mn-induced neurotoxicity, but also identify novel targets for strategies to combat manganism and diseases related to dopaminergic neuronal dysfunction, such as PD. Therefore, in this proposal, we will study the mechanism of REST-induced neuroprotection against Mn toxicity and role of REST in TX-induced protective effects in Mn neurotoxicity.